Research Program - Cancer Prevention & Control

ABSTRACT
The LCCC Consortium is comprised of Georgetown Lombardi Comprehensive Cancer Center, based in
Washington, DC (LCCC-DC) and the John Theurer Cancer Center of Hackensack Meridian Health, based in
Hackensack, NJ (LCCC-NJ). As the nexus for population sciences–focused research in the Consortium, the
mission of the Cancer Prevention and Control (CPC) Program is to conduct innovative and impactful
population sciences research across the translational continuum, from discovery to intervention to policy, to
help alleviate the burden of cancer. A unique aspect of LCCC CPC is its capacity to transform findings
effectively through the phases of this continuum within and across each of the program’s three scientific aims.
Aim 1: Investigate genomic, biologic and other risks and biomarkers associated with cancer occurrence and
early detection. Aim 2: Develop and translate novel primary and secondary prevention interventions to inform
practices and policies that reduce cancer burden. Aim 3: Conduct clinical–translational and policy-relevant
research on cancer treatments and survivorship. CPC’s work is also crosscutting by focusing on the
genetic/genomic underpinnings of cancer risk and response and cancer disparities within our catchment area.
The program has 25 members, led by Christopher Loffredo, PhD and Kenneth Tercyak, PhD, and includes
faculty from eight departments across the LCCC Consortium institutions. Total peer-reviewed direct funding is
$5.33M ($4.9M LCCC-DC, $424,938 LCCC-NJ), of which $4.23M ($3.86M LCCC-DC, $374,309 LCCC-NJ) is
from the NCI. Program members published 435 peer-reviewed publications during the current funding period,
of which 41% were intraprogrammatic (31% intra- and 10% both intra- and interprogrammatic), 25% were
interprogrammatic (15% interprogammatic, 10% both intra- and interprogrammatic), and 58% involved external
collaborations. Program members used all nine of the Shared Resources. CPC conducts high-impact research
that informs cancer practice and policy in all three specific aims, including breast and lung cancer modeling
that has shaped U.S. Preventive Services Task Force screening guidelines, a U.S. Surgeon General’s report,
and international tobacco policy. In summary, the CPC program brings together 25 well-funded investigators
who are national leaders, have moved the field forward, address key cancer needs in our catchment area, and
are supporting the career development of associate members. These scientists are all cancer-focused, highly
collaborative and productive. The Program structure, membership criteria, and complementary leadership of
senior members from different disciplines, along with the investments of the Cancer Center in recruitment,
institutional pilot funding mechanisms, and provision of Shared Resources, have made this level of productivity
and collaboration possible. Overall, CPC demonstrates research excellence and is unique in its ability to
translate research across the population sciences continuum from discovery to intervention trials to clinical
practice and public health policy.